Optimization of an HCN1-Selective Inverse Agonist for the Treatment of Peripheral Neuropathic Pain

PROJECT SUMMARY/ABSTRACT
In the United States, at least 116 million adults suffer from chronic pain; the associated costs exceed $500
billion/yr. Neuropathic pain (chronic pain associated with aberrant activity in the central and/or peripheral nervous
system) accounts for 18% of patients with chronic pain. Opioid analgesics are routinely prescribed for the
treatment of chronic pain but there are substantial risks involved with such therapy, including physical
dependence, addiction, and fatal poisoning. The goals of this project are to optimize the active pharmacophore
component of our identified lead compound and use that novel molecule to create a potent, non-opioid
therapeutic for the treatment of peripheral sensory neuropathic pain.
Ih current-driven hyperexcitability in sensory neurons contributes to neuropathic pain. We have previously
demonstrated that the widely used and safe general anesthetic propofol (2,6-di-iso-propylphenol), as well as
closely related analogues, are potent HCN1 inverse agonists (i.e., they act as inhibitors of channel function),
markedly sparing other HCN isoforms including those that form cardiac Ih (HCN4 and 2). Importantly, sub-
hypnotic propofol and the non-anesthetic 2,6-di-tert-butylphenol (2,6-DTBP) suppress neuropathic hyperalgesia
while largely sparing normal nociception.
Here we will screen in vitro a compound library constrained by known inverse agonist-site characteristics of
alkylphenol congeners to identify novel potent, selective HCN1 channel inverse agonists; use in silico modeling
to predict and then synthesize additional novel, potent, HCN1-selective molecules; and conduct in vivo studies
using the two most potent of those novel compounds to assess anti-hyperalgesic efficacy and safety. Successful
completion of the proposed work will create an urgently needed, highly-effective, non-opioid, treatment for
neuropathic pain.

Public health relevance
PROJECT NARRATIVE Neuropathic pain is a common clinical disorder for which treatment options are generally ineffective, and often dangerous. Degradation of an individual’s quality of life, combined with substantial societal and monetary costs, make this condition a significant public health issue. The immediate goal of this project is to optimize the active pharmacophore in a compound that specifically inhibits HCN1 channel function, and to verify that it is anti- hyperalgesic when administered orally, thereby creating an urgently needed, highly-effective, non-opioid, treatment for neuropathic pain.